Impact of State Policies on Smoking among Individuals with Substance Use Disorder

Project Summary/ Abstract
Growing evidence supports the need to both recognize smokers with substance use disorder (SUD) as a key
disparity group in evaluating tobacco-related use and disease, and identify strategies to address this disparity.
Smoking frequently co-occurs with other illicit drug and alcohol use and synergistically worsens health. Many
who recover from SUD as they age remain dependent on tobacco and are at higher risk for cancer and other
smoking-related complications, and mortality (smokers with SUD have mortality rates 4 times higher than non-
smokers with SUD). Despite greater nicotine dependence and more difficulty quitting among smokers with
SUD, smokers with SUD often report a strong desire to quit, and tobacco dependence treatment (TDT) is
effective in this population. Moreover, smoking cessation has repeatedly been shown to improve SUD
treatment outcomes, countering the common dismissal of nicotine dependence as a lower priority in SUD
treatment. However, rates of TDT in this population remain low. Recently, many states have expanded
Medicaid coverage of TDT, but it is unclear whether this has increased use of treatment services in this
vulnerable group. Tobacco tax and other tobacco control policies have also successfully reduced smoking
rates generally, but effectiveness for smokers with SUD is unknown.
We propose to assess the impact of expanded TDT coverage and tobacco excise taxes on use of TDT
services, smoking intensity and quit rates for smokers with SUD using the 2004-16 Medicaid Analytic Extract
(MAX) claims data from all 50 states, and the 2004-2018 National Survey of Drug Use and Health (NSDUH),
merged to datasets of state Medicaid benefits and state-, city-, and county-level tobacco policies. Taking
advantage of variation within and between states over time, we apply rigorous methods (difference-in-
difference analyses and individual fixed-effects models) to assess causal effects of tobacco cessation policies.
In Aim 1, we test the effect of Medicaid TDT coverage on initiation and maintenance of TDT and on quitting
smoking among Medicaid beneficiaries with SUD. In Aim 2, we test the effect of increasing cigarette excise
taxes on the intensity of smoking and smoking cessation in a broader national sample of individuals with SUD.
In Aim 3, we assess the combined effects of TDT and tax policies on tobacco use among Medicaid
beneficiaries with SUD.
We hypothesize that insurance coverage of TDT incentivizes TDT treatment-seeking, that rising taxes create
strong incentives to quit, and that both policies together will amplify quitting rates. We have worked closely with
stakeholders to propose analyses that inform decision-makers in complex real-world policy environments with
hard-to-reach populations, and we incorporate a dissemination plan that lays the groundwork for actionable
policy changes by targeting state tobacco control managers, state SUD services agencies, SUD treatment
providers reluctant to incorporate TDT, and integrated behavioral health providers.

Public health relevance
Project Narrative Higher sustained tobacco use among smokers with substance use disorder (SUD) is associated with significantly higher mortality rates than non-smokers with SUD and the general population, and is attributed to: higher nicotine dependence, reinforcing and synergistic effects of concurrent substance use, and poor access to effective tobacco dependence treatment (TDT). We propose to assess the impact of expanded coverage of TDT in Medicaid as well as tobacco excise taxes on use of TDT services, smoking intensity, and quit rates for smokers with SUD; we further propose to assess the combined effect of Medicaid coverage of TDT alongside excise taxes on these outcomes. We have worked closely with stakeholders to propose analyses that inform decision-makers in complex real- world policy environments with hard-to-reach populations, and we incorporate a dissemination strategy that will lay the groundwork for actionable policy changes in health care and regulatory, environments by targeting state tobacco control managers, individual state agencies for SUD services, SUD treatment providers reluctant to incorporate tobacco cessation, and integrated behavioral health providers.